Targeting components of distress tolerance

PROJECT SUMMARY
To decrease the worldwide burden of mental illness, it is essential to understand how precise mechanisms
underlying treatments influence transdiagnostic symptoms of psychopathology. The goal of this R15 AREA
award is to specifically target distress intolerance, a transdiagnostic vulnerability factor for psychopathology
that tends to improve with psychotherapy. A critical barrier to understanding how psychotherapy improves
distress tolerance (and subsequent symptoms of psychopathology) is the lack of knowledge of how specific
treatment elements influence thoughts, feelings and emotion regulation behaviors used during distressing
states. The objective of this R15 AREA grant is to evaluate and intervene on self-efficacy for withstanding
distress and willingness to experience distress, which are the components theoretically proposed as core to
distress tolerance, to see how they influence emotion regulation behaviors used in daily life, and how they
ultimately reduce symptoms of psychopathology. To accomplish this, we will (Aim 1) use ecological momentary
assessment (EMA) to evaluate associations between willingness, self-efficacy, use of engagement-based
emotion regulation (i.e., labeling, processing, curiously exploring, sharing emotions) and use of
disengagement-based emotion regulation (i.e., distraction, avoidance, procrastination, denial, thought
suppression, expressive suppression) in daily life. We will then randomly assign participants to one of four
single session in-person interventions: (1) willingness, where participants will link their core values to
experiencing emotion; (2) self-efficacy, where participants will engage in an emotional exposure using self-
compassionate self-talk, (3) a combined condition, or (4) a psychoeducational control. The effects of the
intervention will be assessed on (Aim 2a) a second week of EMA in which participants will be reminded to use
their new skill when they report distress, (Aim 2b) a third week of EMA when reminders are removed, and on
(Aim 3) transdiagnostic symptoms of psychopathology assessed between each week of EMA and after a one
month followup. The central hypothesis is that greater momentary willingness and self-efficacy influence
greater use of engagement and lower use of disengagement behaviors, and together changes in these
components of distress tolerance underlie transdiagnostic symptom improvement. The proposed research is
significant because it explores how specific treatment elements influence daily functioning, thus revealing how
psychotherapy enacts symptom change. The proposed research is innovative because it combines several
established but underused methods (EMA, single session interventions, just-in-time intervention) in an
experimental therapeutics framework to examine how distress tolerance contributes to improved mental health.
This grant will form the foundation of a series of future directions in exploring the importance of treating
distress tolerance and assessing treatment effects on real-world, dynamic psychological processes.

Public health relevance
PROJECT NARRATIVE This project aims to evaluate distress tolerance as a mechanism of psychotherapeutic change by specifically exploring willingness to experience distress and self-efficacy for withstanding distress on emotion regulation strategies used in daily life and subsequent symptoms of psychopathology and well-being. The objectives of this proposal are consistent with the goals of the NIH Academic Research Enhancement Award (AREA) R15 program and will have a significant impact on public health by evaluating specific therapeutic skills and how they target real-world actions taken to manage upsetting emotions. This project uses an experimental therapeutics approach and fits with the strategic mission of the NIMH to improve both prevention and treatment for a key transdiagnostic mental health concern.